Rhode Island Laboratory Flexible Funding Model

Laboratory Flexible Funding Model
RFA-FD-25-007
RHODE ISLAND DEPARTMENT OF HEALTH
Project Summary/Abstract:
WHAT ARE THE MAJOR GOALS OF THE PROJECT?
The Rhode Island State Health Laboratories (RISHL) will expand and enhance its food microbiology
and chemistry testing capabilities over the next five years as part of its participation in the LFFM
initiative. The primary aim of this project is to support and strengthen the integrated food safety
system by providing a broader range of testing services in response to emerging food safety threats
and national concerns regarding the food supply. RISHL’s laboratory staff, including the Chief
Environmental Laboratory Scientist and the Chief Biological Laboratory Scientist, will lead the
project. They will be supported by a skilled team of microbiology and chemistry experts, as well as
quality assurance officers.
The project will ensure RISHL’s continued ability to monitor and address chemical and
microbiological contamination in food, providing essential data to safeguard public health. RISHL’s
ISO/IEC 17025-certified laboratory, specializing in food Microbiology and chemistry, will collaborate
with the Rhode Island Department of Health's Center for Food Protection (CFP), which collects and
analyzes food products produced within the state. Based on the results of testing, CFP may initiate
public health responses, and RISHL will facilitate follow-up testing as necessary.
This project aligns with the broader health mission of enhancing food safety and preventing
contamination, ultimately contributing to the national effort to maintain a safe and secure food
supply. The research design includes rigorous testing methodologies and collaboration with state
and federal food safety networks to achieve the outlined objectives. The focus will be on increasing
laboratory testing capacity and responsiveness to emerging food safety concerns.
Please refer to the individual grant components’ Project Summaries for more information.
A1-Human Food Micro B1- Human Food Chem
A2- NARMS B4- Chem MD/MV
A7- Micro MD/MV B5- Chem C/CD
A8 – Micro C/CD

Public health relevance
Laboratory Flexible Funding Model RFA-FD-25-007 RHODE ISLAND DEPARTMENT OF HEALTH Project Narrative: RISHL will support the integrated food safety system by working with our FDA and state partners to protect the national food supply. The RISHL will contribute to this effort by generating surveillance data on targeted food commodities that have historically posed a risk to public health. In addition, the RISHL will coordinate with the FDA to develop and validate new microbiological/chemical food testing methods and to expand its microbiological/chemical food testing capabilities.